2017 Cell Growth and Proliferation Gordon Research Conference & Gordon Research Seminar

Summary/Abstract The 2017 Gordon Research Conference on Cell Growth and Proliferation will be held at Mount Snow Hotel, West Dover, Vermont, from July 9 to 14, 2017. The conference will bring together approximately 170 investigators (junior and senior scientists, postdoctoral fellows, graduate students, as well as people from industry and government) for discussions of recent advances in the area of cell proliferation, with special emphasis on cancer. The topics of nine scientific sessions will be: (i) Normal and cancer stem cells; (ii) Analyses at single cell resolution; (iii) Linking cell proliferation and metabolism; (iv) Normal and cancer cell cycles; (v) Cell cycle, proteolysis and cancer; (vi) Chromosome separation, aneuploidy and cancer; (vii) Cell proliferation, DNA damage and cancer; (viii) Cancer; (ix) Cell cycle-focused therapies. In addition, there will be four poster sessions. This conference will be a timely and important meeting in the area that is rapidly growing. This conference is fairly unique in that it provides a format that brings together an extraordinary range of investigators whose collective approaches encompass cell biological, biochemical, molecular and genetic methods that address central issues in the regulation of cellular proliferation. The Gordon Conference format provides a relaxed environment that encourages informal and open discussions among the participants, and this in turn, fosters initiation of collaborative efforts and stimulates future research directions.

Public health relevance
Narrative The Gordon Research Conference “Cell Growth and Proliferation” will bring together a diverse group of investigators to exchange the latest unpublished results and to discuss new ideas. This will accelerate our research on cell proliferation, ultimately leading to better treatments of diseases and conditions such as cancer or aging.